Using discourse analysis to identify and predict leadership performance in dynamic healthcare teams

? DESCRIPTION (provided by applicant): Leadership is imperative in teams that form quickly and perform dynamic tasks, such as trauma teams. The leader is required to construct a leader-follower relationship extremely quickly, and then effectively apply their leadership to rapidly determine care goals, direct others toward achievement of those goals and update the goals as required. This project will analyse the discourse used by action team leaders to establish leadership relationships, mobilize resources and accomplish task goals. At the conclusion of this study, we will be able to predict the impact of specific types of leader and team discourse on time to critical intervention, an approximation of performance in trauma resuscitation teams.

Public health relevance
PUBLIC HEALTH RELEVANCE: Critically injured patients have up to a four-fold higher risk of death from errors than general hospital patients, and nearly half of the preventable deaths related to errors occur during the initial resuscitation phase of treatment. Leadership is criticalin these teams but little is known about how leadership is effectively executed in these situations. This project will improve patient care by analyzing the exact mechanisms of discourse that leaders use to optimize their team's performance toward efficiently achieving clinical care goals.